Impact of brain estrogens on cognition and brain aging in a non-human primate

SUMMARY
Aromatase inhibitors (AIs) are drugs that inhibit estrogen synthesis and that are prescribed to prevent
the recurrence of estrogen responsive breast cancers. However, AIs, such as the commonly prescribed Letrozole
(LET), are associated with severe side-effects that further burden the quality of life, including insomnia, hot
flashes, depressive symptoms and cognitive deficits. The precise mechanisms by which AIs may give rise to
these CNS symptoms remain unclear and difficult to study in humans, as control for individual differences in
disease severity, treatment history and experienced stress is lacking. Furthermore, AI treatment is recommended
for 3 to 5 years, yet little is known about the effects of long-term AI use on the brain and behavior, especially
with regards to age-related cognitive decline and Alzheimer's disease (AD) risk. We propose to develop a primate
model for AI-induced CNS effects to advance our knowledge in this area and facilitate the design of novel
therapeutics.
This application uses the marmoset (Callithrix jacchus), a small primate with a brain architecture, sleep
patterns, cognitive abilities, emotional responses and thermoregulation patterns that are comparable to those of
humans (1) to study the effects of chronic LET use on the brain and behavior and (2) to test whether DHED, a
prodrug that delivers E2 selectively to the brain, can effectively and safely prevent LET-associated adverse
effects.
To achieve these aims, middle-aged male and female marmosets treated with LET, LET + DHED or
Vehicle for 3 years will be studied longitudinally for changes in sleep/wake patterns, cognitive performance,
emotional regulation, and thermoregulation. The monkeys will be outfitted with an activity monitor for sleep/wake
patterns analysis. Cognitive function will be assessed via an automated computerized battery. Thermal imaging
will be used to measure changes in facial skin temperature during a thermal challenge. Emotional regulation will
be assessed by measuring heart rate variability and facial skin temperature in monkeys viewing emotional and
neutral videos. Following these in vivo behavioral assessments, analyses of brain tissues from underlying brain
regions (hypothalamus, hippocampus, prefrontal cortex, locus coeruleus) will be carried out to quantify gene
expression of selected genes, tauopathies, β-amyloid deposition and neuronal excitability.
The results will have important translational applications for AI-treated patients by (1) characterizing the
effects of AIs on multiple neural and behavioral outcomes; (2) determining whether long-term estrogen
suppression promotes the development of an AD-like phenotype and (3) whether providing the brain with an
alternate source of estrogen can counteract the adverse effects of AIs on the brain and behavior.

Public health relevance
NARRATIVE Breast cancer patients using aromatase inhibitors (AIs) as an adjuvant therapy often report severe side effects, including hot flashes, cognitive impairment, insomnia and mood changes. Despite long-term use in humans, little is known about the long-term effects of AIs on brain function. This proposal uses a primate model to understand how AIs affect the brain and behavior and to test whether a drug that delivers estrogens exclusively to the brain can safely alleviate these deficits.